Core C: Biostatistics and Data Management Core

CORE C
Abstract
The Biostatistics and Data Management (BDM) Core is responsible for all statistical and data management
activities for each of the Myeloproliferative Neoplasms Research Consortium (MPN-RC) projects and cores
including all clinical trials and the tumor bank. Each of the projects presented in this application reflects input
from the Director of the BDM Core (Dr. Amylou Dueck, Mayo Clinic) on the design, data management, and
biostatistical analysis plan. The BDM Core is constituted to provide state-of-the-art statistical collaboration and
data management support to all clinical and translational research projects. The biostatistical and data
management components of this Core are integrated at Mayo Clinic under the leadership of Dr. Amylou Dueck.
Dr. Dueck and her team are highly published in the MPN field and notable experts in MPN clinical trial design
and statistical analysis of patient outcomes. The Core will provide statistical expertise including experimental
design for laboratory studies; statistical modeling; statistical analysis of high-dimensional data, patient-reported
outcomes, and correlative studies using biospecimens; and state-of-the-art clinical trial design, monitoring, and
statistical analysis within an efficient platform protocol. The Core will also provide advanced web-based data
management through Mayo Clinic’s data management infrastructure with all clinical trial and tumor bank data
captured in REDCap. This web-based system provides ease of use coupled with electronic patient
questionnaires, online calendaring/querying/tracking, robust data validation routines, and straightforward
integration with SAS/R for seamless overall statistical analysis. Dr. Dueck is an experienced co-investigator on
translational and clinical research program grants in hematologic malignancies with extensive collaborations
with the MPN-RC investigators. The competencies of the biostatistical and data management components of
this Core provide the full spectrum of expertise and operational capacity needed to actively collaborate with the
translational and clinical investigators in the formulation of the research protocols, in implementation according
to internationally accepted requirements, and in the statistical analysis of the data from clinical, laboratory, and
translational studies. The BDM Core is a critical component of the MPN-RC.

Public health relevance
CORE C Project Narrative The Biostatistics and Data Management Core will provide the Myeloproliferative Neoplasms Research Consortium (MPN-RC) investigators access to state-of-the-art integrated statistical and data management resources. It provides a mechanism for consistent and compatible data handling and tracking among the projects and cores and ensures the work across the MPN-RC is accomplished in a timely manner with the utmost statistical rigor. Providing oversight of all MPN-RC related statistical and data management activities through this Core allows for synergies and efficiencies for systematic and programmatic initiatives beyond what can be achieved with individual statistical teams for each project.